SUPPORT SERVICES FOR INTEGRATIVE EPIDEMIOLOGICAL STUDIES

Chile Biliary Longitudinal Study (BiLS)
The Chile BiLS is a cohort of women with gallstones in Chile, which has among the highest rates of gallbladder cancer (GBC) in the world. By providing prospective data taken among individuals with gallstones and extensive biologic sample collection, Chile BiLS offers the opportunity to study what drives the development of GBC in the context of gallstones.
Contractor Support Activities include:
Technical Requirements:
• Initial Transition
• Study Initiation and Liaison
• Preparation of Study Materials and Procedures
• Subject ID and Data Collection
• Data Preparation and Data Processing
• Data Analysis, QC and Reporting